Discovery and Characterization of Genetic Risk Loci in Sjogren's Syndrome

ABSTRACT
Sjögren’s syndrome (SS) is a complex rheumatic disorder distinguished by autoimmune targeting of exocrine
glands. Severe clinical manifestations may include debilitating dryness, pulmonary dysfunction, neuropathies,
profound fatigue, and lymphoma. Salivary gland lesions involve activated ductal and acinar epithelial cells as
well as irreversible immune-mediated tissue damage. Diagnosis and treatment of SS are notoriously difficult.
Our group leads the international Sjögren’s Genetics Network (SGENE) comprised of 26 SS research groups
dedicated to understanding the genetic architecture of SS. SGENE studies have identified 15 of the 16 SS risk
loci thus far established in European-derived populations. SS risk loci coalesce in Type I and Type II interferon
(IFN), NFkB signaling, antigen presentation, autoantibody production and lymphocyte trafficking pathways. Our
genetic studies have provided strong evidence supporting a pathogenic role in SS from various innate and
adaptive immune cell subsets, however, how these cell types are functionally affected by SS risk alleles remain
poorly understood. Importantly, these studies also suggest new therapeutic targets, such as IL12 signaling, for
which biologic therapies have been developed for related autoimmune diseases, but not previously considered
in SS. Preliminary data in 2,809 SS cases suggest >40 additional candidate loci that warrant further study. Using
insights from our genetic studies, we have developed a novel model of disease pathogenesis that differentiates
3 major patient subsets based on distinct molecular mechanisms. Our overall goals are to develop a more
complete model of SS genetic determinants and to identify biomarkers that reflect the distinct molecular
mechanisms represented in our disease model that could be developed into clinical tools for stratifying patients.
In Aim 1, we will greatly expand our current genome-wide association studies by leveraging our unique access
to samples, laboratory and clinical data from well-characterized SGENE cohorts (>10,000 SS cases). In Aim 2,
we will test known SS risk variants for cell specific cis-regulatory effects on transcription in salivary gland tissues.
Banked tissues obtained from minor labial gland biopsies from subjects (n=200) classified into the 3 major patient
subsets defined in our proposed disease model, plus a subset of patients with lymphoma and controls will be
evaluated. Spatial transcriptomic technologies will be utilized to generate gene expression data in which
morphological context is retained at nearly single cell resolution. In Aim 3, we will integrate genetic, transcriptomic
and proteomic data to develop multidimensional panels of soluble immune mediators that can serve as peripheral
biomarkers for these patient subgroups to facilitate patient stratification. These studies will expand our
understanding of genetic contributors to SS, identify cell-specific functional effects on transcription, foster
development of new clinical tools for more accurate diagnostics, and establish the feasibility of rapid clinical
translation for therapeutic targeting in well-defined patient subsets using novel and existing biologics directed
against pathways and cell types that drive this complex autoimmune disorder.
!

Public health relevance
PROJECT NARRATIVE Sjögren’s syndrome (SS) is a complex autoimmune disorder, affects 2-3.1 million Americans, involves dysfunction of moisture-producing glands that is mediated by immune responses, and can result in irreversible tissue damage and serious complications such as neurological problems, lung disease and cancer. This project involves a large international group of SS experts collaborating to identify and characterize genetic risk factors that alter the function of various cell types in salivary glands and the immune system. This new knowledge is critical for identifying effective ways to subset patients based on different causes of SS, developing better clinical tools to diagnose patients earlier before tissue damage occurs, identifying patients at high risk for lymphoma and other poor outcomes, and helping to establish the feasibility of novel candidate therapies and repurposing existing drugs that may be effective in SS but have not yet been considered for clinical trials. !